Antibody-based Contraceptive MPTs: Advancing the Human Contraceptive Antibody (HCA) through Clinical Trials

CRC OVERALL – ABSTRACT
The overarching goal of our Contraception Research Center (CRC) is to develop
innovative monoclonal antibody (mAb)-based contraceptive and multipurpose prevention
technology (MPT) products with the potential to improve the lives of millions of women globally
by addressing two concurrent reproductive health crises: an unacceptably high rate of unintended
pregnancies in both developing and developed countries, and an epidemic of sexually
transmissible infections (STIs). With funding from NIAID we developed a vaginal film, MB-66,
containing mAbs against HIV-1 and HSV-2 [the first components of our MPT product]. MB-66
was safe and showed good ex vivo efficacy in a Phase 1 Clinical Trial. Under our current NICHD-
funded CRC program we engineered, produced and characterized a GMP-grade human
antisperm mAb “Human Contraception Antibody (HCA)”, and ZB-06, a vaginal film containing
HCA for topical vaginal application. We obtained an exploratory IND, and are currently testing ZB-
06 in a Phase 1 Clinical Trial in women with safety and exploratory efficacy (postcoital test)
endpoints. Preliminary data from the first six women enrolled in the clinical trial indicate that ZB-
06 is safe and highly effective at preventing motile sperm from entering the endocervix, a key
correlate of contraceptive efficacy.
We are seeking to renew our CRC program to advance ZB-06 through further clinical trials.
In Project 1, ZabBio will improve upon and scale up the production of ZB-06 for use in IND-
enabling studies, and in the proposed Phase 1 and Phase 2a clinical trials. ZabBio will file all
paperwork required by the FDA to obtain an IND for the clinical trials, maintain the IND and
monitor the clinical trials. Project 2, to be conducted at Eastern Virginia Medical School and the
University of Texas San Antonio, will be responsible for the conduct of the two clinical trials: 1) a
Phase 1 safety and PK study of single dose vs. multiple dose application of ZB-06, and 2) a Phase
2a dose-finding study of ZB-06 film with safety and postcoital test efficacy endpoints. Project 3,
based at Boston University School of Medicine and Magee-Women’s Research Institute, will
improve upon the vaginal film design, and conduct essential safety studies to support the clinical
trials. An Administrative Core will provide leadership and fiscal management for all projects, and
database and statistical support for the clinical trials. By the end of the project we expect that ZB-
06 will be positioned for Phase 2b contraceptive efficacy testing by the NIH Contraceptive Trials
Network.

Public health relevance
Narrative The goal of the Boston University Contraceptive Development Research Center is to develop a new woman-controlled on-demand contraception method based on the use of a vaginal film that releases an antisperm monoclonal antibody that prevents sperm from fertilizing the egg. There is an urgent need for more contraception choices as nearly half of all current pregnancies are unplanned. Unplanned pregnancies disproportionately affect young women and contribute to maternal and child mortality and intergenerational cycles of poverty and poor health.